Early Detection of Progressive Visual Loss in Glaucoma Using Deep Learning

Glaucoma, a leading cause of irreversible blindness, disproportionately affects veterans. While often progressing
slowly, glaucoma can also progress rapidly, and especially given the variability of standard visual-field (VF) tests
to monitor progression, it currently can be challenging to determine those individuals needing a more aggressive
treatment plan. Veterans may experience permanent loss of vision (and corresponding vision-related quality of
life) while waiting for subsequent tests to show VF loss progression (and thus indicating a change in treatment
is needed). Structural optical coherence tomography (OCT) measures, such as the thickness of the macular
ganglion cell layer (GCL), retinal nerve fiber layer (RNFL) and optic disc morphology can also be used to help
monitor progression. However, existing clinical use of global parameters to assess glaucoma progression may
be insensitive to worsening of focal defects. It is also not known how differing spatial patterns of progression
affects quality of life. There is an unmet clinical need for simple-to-use approaches to more accurately estimate
future progression and corresponding quality-of-life measures. We will use a specific type of deep-learning
approach, called deep variational autoencoders (VAEs) to provide a novel standardized and sensitive approach
to monitoring glaucomatous progression, comparable to a glaucoma expert. Our specific aims are as follows:
1. Evaluate how well image-based deep-learning variational autoencoder (VAE) models can be used
to monitor a patient’s current glaucomatous progression. This aim will first involve training and
evaluating a separate deep VAE model for each image-based structure of interest as well as a deep VAE
model for 24-2 visual field threshold data. Once trained, each VAE model will allow for the extraction of the
so-called latent variable values given the input image. The ability of these latent variable values to monitor
change over time will be compared (in an independent test set) to standard global and regional parameters.
Because of their ability to naturally capture both global and local changes, the latent-variable approach will
be able to better detect changes over time compared to current clinical reports.
2. Evaluate how well image-based deep-learning variational autoencoder (VAE) models can be used
to predict a patient’s future glaucomatous progression. In this aim, we will first develop an approach
for predicting future latent-variable representations of structure/function based on learning from a prior time
series of values. Once determined, future latent values will be mapped back to their original
structure/function representations using the trained “decoder” part of the VAE. Such an approach will
provide a clear advantage for a clinician in having visual spatial representations of future structure and
function trajectories to optimize early treatment decisions.
3. Evaluate how latent variables from a novel binocular VAE model relate to visual quality-of-life
measures. In this aim, we will first develop an additional VAE model to take into account binocular vision
(what the patient sees with both eyes open) and then relate latent factors from each model to quality-of-
life measures in a cross-sectional fashion. We hypothesize that binocular VAE models of structure and
function will be more predictive of visual quality-of-life measures than current methods, helping to
prioritize and guide treatment.
Successful completion of these aims is expected to have positive impact to help veteran glaucomatous
patients avoid permanent vision loss at an early disease stage and maintain vision-related quality of life.

Public health relevance
This project will determine whether a specific type of deep-learning approach to artificial intelligence, utilizing deep variational autoencoders (VAEs), is as sensitive as a glaucoma expert for assessing glaucoma progression, will predict future image-based representations of structure and function in eyes with glaucoma, and will provide better correlation with quality-of-life outcome measures than with clinical data currently used. If so, incorporation of VAEs into clinical practice will lead to better diagnostic capability, earlier treatment intervention, and better visual and quality-of life outcomes in our veterans suffering from glaucoma.